Building Diversity in Biomedical Sciences

The Building Diversity in Biomedical Sciences Program responds to RFA-HL-16-008
and seeks to continue its nearly 25-year tradition of excellence initiated under the aegis
of the original NHLBI T35-sponsored short term minority training programs. In the past
fifteen years, our program has trained 237 undergraduate students who are members of
groups recognized by NIH as underrepresented in biomedical science. All of these
trainees have completed their undergraduate degrees or remain enrolled. Continued
contact with nearly 97% of these alumni reveals that after graduation 70% have entered
graduate health science degree programs and a total of 90% are engaged in the
biomedical workforce. In the coming period, we will build on this record of success by
providing an intensive 10-week mentored summer research experience with a focus on
cardiovascular and pulmonary diseases and issues of direct concern to NHLBI. The
training program will be informed by educational scholarship as well as biomedical
science. Research will be supplemented by training in oral and written communication
through experiences that build skills and enhance self-confidence. Trainees will be
exposed to the ways basic science can directly impact health through a Clinical
Connections Workshop and learn about the breadth of biomedical science careers
through sessions on IDPs and career planning. A group of 40 faculty members whose
research is aligned with the NHLBI mission will train 15 undergraduates each summer. A
formative and summative evaluation plan will support the program and be used by the
Directors and the Program Steering Committee to modify the program as appropriate.

Public health relevance
Improving the health of the American people, especially in the area of chronic diseases such as cardiovascular disease, pulmonary disorders and related conditions, relies on a strong biomedical workforce that is prepared to address these health problems through basic and translational research. Our program trains talented undergraduates from groups underrepresented in biomedical science. The program philosophy is based on findings from educational scholarship. We offer a rich summer research experience with in depth career mentoring of talented undergraduates thereby preparing our trainees for advanced study in biomedical research. Our students learn to understand key health issues related to the NHLBI mission and come to understand how these problems can be addressed through research.